The Pallidohabenular System in Parkinsonism

SUMMARY
The basal ganglia serve many behavioral functions, ranging from the regulation of movements and cognition to
the modulation of valence and mood. This functional heterogeneity is reflected in the composition of the principal
output nucleus of the primate basal ganglia, the internal pallidal segment (GPi). This nucleus contains two distinct
populations of projection neurons. A major group of cells in the core of GPi projects to the ventral thalamus (and
other targets) and is known to be involved in motor functions. Much less explored is a second population of
neurons that is confined to the GPi periphery and projects exclusively to the lateral habenula (LHb). Studies in
monkeys and rodents have shown that this group of cells communicates negative valence signals to the LHb
which, in turn, regulates the activity of dopaminergic and serotonergic brainstem areas that are involved in the
control of reward responses and mood. Based on literature evidence and our preliminary data, we hypothesize
that pallidohabenular neurons differ from the pallidothalamic cells in terms of their synaptic connectivity,
neurotransmitter content and electrophysiological responses to dopamine depletion in the parkinsonian state.
To test this hypothesis, the following studies are proposed: In aim 1, we will analyze the synaptic connectivity
and prevalence of cortical glutamatergic inputs to pallidohabenular neurons, and study their anatomical
relationship to other afferents in normal and MPTP-treated parkinsonian rhesus monkeys. In aim 2, we will
compare the neurotransmitter phenotype and synaptic architecture of pallidohabenular terminals in these
animals. To achieve these goals, we will combine high-resolution 3D immuno-electron microscopy with viral
vector tracing methods. These anatomical experiments will generate in-depth knowledge of the microcircuits that
regulates the activity and synaptic transmission of primate pallidohabenular neurons in the normal and
parkinsonian states. Studies under aim 3 will functionally assess parkinsonism-associated activity changes in
pallidohabenular neurons and probe their impact upon LHb neurons, using state-of the art optotagging
approaches to identify these cells in vivo. The available evidence leads us to hypothesize that the activity of
pallidohabenular neurons is increased in the parkinsonian state, resulting in a pathological increase of LHb
neurons activity. It is possible that these rate changes are associated with oscillatory synchrony, as is the case
for other GPi neurons. Increased activity along the pallidohabenular axis could specifically contribute to the
emergence of parkinsonism-associated depression and other psychiatric features of Parkinson's disease. Given
the importance of Deep Brain Stimulation (DBS) therapy for the treatment of parkinsonism, we will also examine
whether electrical stimulation in the subthalamic nucleus alters the firing of LHb neurons, and whether such
changes correlate with the emergence of depressive-like behaviors. Taken together, the results of this project
will increase our knowledge of the anatomy and function of the primate pallidohabenular system under healthy
conditions, and elucidate changes within this system in the parkinsonian state.

Public health relevance
NARRATIVE The basal ganglia are involved in many motor and non-motor functions, including the regulation of valence and mood. This project will study, in non-human primates, the anatomical connections and parkinsonism-associated pathophysiological changes of pallidal projections to the lateral habenula, which is involved in the processing of negative valence. Results of this project will further our understanding of the pathophysiology of the palllidohabenular projection in parkinsonism, and may help us to better understand the origin of some of the psychiatric aspects of Parkinson’s disease, such as depression.